Mechanisms Underlying Glial Regulation of Neuronal Excitability in Drosophila

We propose to use Drosophila as a model system for determining how glial Ca2+ oscillations couple to K+ buffering and neurotransmitter uptake to regulate neuronal excitability. Glial cells, including astrocytes, can increase their intracellular Ca2+ both spontaneously and in response to neuronal activity, and growing evidence indicates astrocytic Ca2+ signaling acutely influences neuronal physiology. However, little is known about the molecular machinery underlying different types of glial Ca2+ signals and how they act to regulate neuronal excitability. Like mammals, we have found that Drosophila glia display microdomain Ca2+ oscillatory activity that acutely regulates neuronal function and behavior. Drosophila has two main glial subtypes that are intimately associated with neurons in the CNS and that share features with mammalian astrocytes -- astrocyte-like glia and cortex glia. The Drosophila CNS is compartmentalized into the cell cortex that contains neuronal cell bodies, and the synaptic neuropil that contains all neurites and synapses. Astrocytes and cortex glia are similarly compartmentalized into these brain regions, with astrocytes associating with synapses and cortex glia surrounding neuronal somas that are devoid of synapses. As such, Drosophila provides an ideal system to study spatially-localized glial-neuronal signaling at somas versus synapses. We have identified mutations in a Drosophila cortex glial-specific NCKX exchanger that controls microdomain Ca2+ oscillations and that acutely triggers neuronal seizures when inactivated. In addition, we found that ectopic glial expression of a heat-activated TRPA1 channel can induce rapid Ca2+ influx and neuronal seizures in cortex glial, or rapid paralysis and neuronal silencing when expressed in astrocytes. Using unbiased genetic suppressor screens for the behavioral seizure and paralysis phenotypes, we have generated initial data that indicates Ca2+ influx controls membrane trafficking of either leak K+ channels or neurotransmitter transporters, providing an unexpected and exciting connection between glial Ca2+ oscillations and the more well-known roles of glia in K+ buffering and neurotransmitter clearance. In the current application, we propose experiments that will provide a foundation to examine how glial Ca2+ oscillatory activity modulates spatial K+ buffering and neurotransmitter uptake to acutely modulate neuronal excitability through either glial-soma or glial-synapse interactions, respectively.

Public health relevance
This research will define key molecular pathways that underline how glia acutely regulate neuronal activity in the Drosophila model. Alterations in glial function have been linked to numerous neurological and psychiatric diseases of the human brain. By defining how glial Ca2+ oscillations regulate and control established glial functions like spatial K+ buffering and neurotransmitter uptake, our research will provide a foundation for future development of therapeutic approaches for brain diseases that arise secondary to altered glial function.